Dysregulated RNA metabolism in cell fate of maternal diabetes-induced neural tube defects

ABSTRACT
Pregestational diabetes induces neural tube defects (NTDs), the second most common birth defects. We and
others have shown that cellular stress, altered cell fate and epigenetic and non-coding RNA alterations are
critically involved in diabetic embryopathy. How neuroepithelial cell fate is altered by non-coding RNAs in diabetic
pregnancy is obscure. We showed that restoring miR-322 expression suppressed by maternal diabetes
ameliorated neuroepithelial cell apoptosis and NTDs, revealed that the RNA binding protein RBM47 was a miR-
322 target, and found that exosomes from vascular Flk1 positive progenitors specifically targeted neuroepithelial
cells during neurulation. Exosomal delivery of the RBM47-expressing DNA vector to embryos resulted in NTDs.
RBM47 binds to the long non-coding RNA (lncRNA), NEAT1, to stabilize it. Exosome-mediated delivery of NEAT1
to embryos induces NTDs. Thus, we hypothesize that maternal diabetes dysregulates RNA metabolism by
repressing miR-322, upregulating RBM47 and stabilizing NEAT1 in the neuroepithelium. Restoring miR-
322 or deleting either Rbm47 or Neat1 attenuates neuroepithelial cell apoptosis, senescence,
neurogenesis impairment and NTD formation. miR-322 deletion or overexpressing either Rbm47 or Neat1
mimics diabetes to alter cell fate and induce NTDs. To test our hypothesis, we proposed three specific aims.
Aim 1 will determine whether miR-322 is essential for neurulation and its reduction contributes to maternal
diabetes-induced neuroepithelial cell dysfunction and NTD formation. We hypothesize that maternal
diabetes-repressed miR-322 causes senescence and inhibits neurogenesis by altering gene expression in spatial
and cell-type specific manners in the neuroepithelium. Aim 2 will investigate whether increased RBM47
mediates the teratogenicity of diabetes by affecting neuroepithelial cell fates leading to NTD formation.
Our hypothesis is that miR-322 targets RBM47 for degradation and maternal diabetes increases RBM47
expression by repressing miR-322, and that RBM47 conditional deletion in the neuroepithelium ameliorates
neuroepithelial cell fate alteration and NTD formation in diabetic pregnancy. Aim 3 will determine whether
increased NEAT1 mediates the teratogenic effect of maternal diabetes by altering neuroepithelial cell
function and ultimately promoting NTD formation. We hypothesize that maternal diabetes increases NEAT1
via RBM47-mediated stabilization and that NEAT1 deficiency reverses neuroepithelial cell fate alterations and
blocks NTDs in diabetic embryopathy. Alteration in miRNA, RNA binding protein, and lncRNA alterations are
involved in human NTDs. Revealing this mechanism in linking miRNA to lncRNA via RBM47 is a novel epigenetic
regulation in diabetic embryopathy.

Public health relevance
PROJECT NARRATIVE Pregestational maternal diabetes induces neural tube defects, but the underlying epigenetic mechanism is still elusive. This project will determine the role of altered RNA metabolism by an microRNA, a RNA binding protein, and a long non-coding RNA, in maternal diabetes-disrupted cell fate decisions. The study will provide new mechanistic insights and therapeutic targets for diabetic embryopathy.